Development of Dynamic Resting State Functional Connectivity Machine Learning Framework for Dementia

Project Summary/Abstract
The objective of this proposal is to provide a robust course of training for Fei Jiang, Ph.D., a candidate with
an excellent foundation in statistical and machine learning research, to enable her to become an independent
investigator in the ﬁeld of quantitative data analysis and statistical/machine learning methods development for
neuroimaging research. The proposed research aims to extract dynamic resting-state functional connectivity
from multimodality imaging and use them for the prediction of cognitive decline. The central hypothesis is that
the resting state functional connectivity changes over the imaging acquisition period, and this dynamic pattern is
crucial for the optimal prediction of cognitive decline. Towards proving this hypothesis, a unique machine learn-
ing framework is proposed to (1) robustly extract dynamic resting-state functional connectivity from multimodality
imaging; (2) identify the important features that are associated with individuals' cognitive scores; and (3) predict
cognitive decline using the identiﬁed important features. Successful completion of the proposed research will
provide the next generation machine learning framework for the extraction and analysis of dynamic resting-state
functional connectivity and lead to potential endpoints that can be used in the assessment of treatment effects.
Recognizing the multidisciplinary nature of the work proposed, the author will be mentored and work closely with
an expert committee from multiple scientiﬁc areas of relevance to the project (Neuroimaging, Neurodegenerative
disease, Biostatistics): Srikantan Nagarajan (primary mentor), Ph.D., Department of Radiology and Biomedical
Imaging, Ashish Raj (co-mentor), Ph.D., Department Radiology and Biomedical Imaging, William W. Seeley (ad-
visor), M.D., Ph.D., Department of Neurology, John Kornak (advisor), Ph.D., Department of Epidemiology and
Biostatistics, Marilu Gorno Tempini (collaborator), M.D., Ph.D., Department of Neurology, Charles McCulloch
(collaborator), Ph.D., Department of Epidemiology and Biostatistics. This committee will be coordinated by Dr.
Nagarajan. The goal is that by the end of the K25, Dr. Jiang will have the requisite knowledge, technical skills,
and expertise to submit a successful R01 proposal that integrates her expertise in statistical and machine learn-
ing methods with a knowledge of the questions and approaches pertaining to imaging in neuroscience, acquired
through this training period.

Public health relevance
Project narrative There is an urgent need to evaluate whether new proposed presymptomatic Alzheimer's disease (AD) treatments are efﬁcacious in preventing cognitive decline. Current clinical endpoints, such as cognitive scores, are too noisy to access the cognitive decline after an intervention; however, neuroimaging can generate better biomarkers to monitor cognitive decline. We aim to develop a machine learning framework to extract useful biomarkers from neuroimaging data to predict cognitive decline, which then can be used as endpoints to evaluate presymptomatic AD treatments.